Adapting and Piloting Behavioral Activation for Veterans with Co-Occurring AUD and Posttraumatic Stress Disorder

Alcohol use disorder (AUD) frequently co-occurs with posttraumatic stress disorder (PTSD) among U.S.
military veterans. Compared to veterans with AUD only, veterans with AUD/PTSD have greater symptom
severity, more psychosocial functioning difficulties, and higher risk of suicide. Many people with AUD/PTSD
perform behaviors aimed at avoiding unpleasant emotions (e.g., drinking to avoid trauma-related nightmares,
skipping social events to avoid anxiety-provoking crowds). These “avoidance behaviors” provide temporary
relief from unpleasant emotions, but they maintain AUD/PTSD and interfere with long-term functioning.
Although treatments for AUD/PTSD exist, they emphasize symptom reduction (not functional improvement)
and have dropout rates as high as 50%. Originally developed to treat depression, Behavioral Activation (BA) is
an intervention that increases daily participation in rewarding, alcohol-free activities relevant to patients’ social,
vocational, and health-related values. Randomized controlled trials (RCTs) adapting BA for other disorders
have shown that BA is efficacious for adults with alcohol/drug use disorders and acceptable to veterans with
PTSD, but BA has not been used to treat co-occurring AUD/PTSD. Additionally, because RCTs of AUD/PTSD
treatments typically emphasize significant mean group differences in AUD/PTSD outcomes, less is known
about the degree to which these treatments yield clinically significant improvements at the individual level.
Individual-level improvements in AUD/PTSD should be evident not only in subjective clinical assessments, but
also in objective measures of geospatial activity. Specifically, patients’ daily geospatial activity is likely to
change as they decrease their avoidance behaviors and increase their engagement in various social,
vocational, and health-promoting activities. Advances in geospatial methods, coupled with discreet and
portable GPS trackers, have made it possible to objectively measure people’s spatial movement within their
communities. Yet although geospatial methods have been used to identify social determinants of alcohol use,
they have not been used to measure response to AUD or AUD/PTSD treatment. As the long-term objectives of
this work are to identify a more acceptable AUD/PTSD treatment option and improve the measurement of
AUD/PTSD recovery, this R34 project will address the following specific aims: (1) adapt BA for use with
veterans with AUD/PTSD; (2) evaluate the feasibility, acceptability, and preliminary effects of BA, relative to
Relapse Prevention, for veterans with AUD/PTSD in a pilot RCT; and (3) explore geospatial analysis of GPS-
collected data as a new approach to measuring AUD/PTSD treatment response. This study will advance
research and practice by piloting a novel application of BA and a novel measure of AUD/PTSD recovery. This
project aligns with the National Institute on Alcohol Abuse and Alcoholism’s special interest in investigating
treatments for patients with AUD and co-occurring disorders, dimensions of functioning and well-being
associated with recovery, and innovative methods for evaluating AUD treatment and recovery.

Public health relevance
Co-morbidity of alcohol use disorder and posttraumatic stress disorder (AUD/PTSD) is prevalent among U.S. veterans, and existing AUD/PTSD treatments are associated with high patient dropout. We will conduct a pilot randomized controlled trial in a sample of veterans with AUD/PTSD to test the feasibility, acceptability, and preliminary effects of Behavioral Activation, an integrated and recovery-oriented treatment, on subjective (clinical) and objective (geospatial) outcomes. This project will improve the lives of the nearly 2 million U.S. veterans with AUD/PTSD by providing them with an effective and more acceptable treatment option for their health and well-being.